LANGUAGE PROCESSING DURING READING

The present proposal examines the principles governing language comprehension in reading. The proposed studies examine the principles underlying the syntactic analysis of sentences, principles determining the semantic interpretation of sentences, and the relation between them. The experiments all involve recording subjects' eye movements as they read sentences or short texts. Average reading time per letter in various critical regions of the sentence is used as a measure of processing complexity, along with the gaze durations associated with each word, total sentence reading time, and the probability of making a regressive eye movement which returns to portions of the text which have already been read.